Community Engagement Core

Summary
The reasons for increased incidence and mortality due to prostate cancer in African-American men could be
due to inherent biological differences and/or socio-economic reasons. Combined strategies based on basic
biological research and community outreach programs are required to combat this disease in the African-
American community. The Center for Cancer Research and Therapeutic Development (CCRTD) focuses on
reducing the burden of prostate cancer disparities through research, outreach, and education. In an effort to
provide information on health disparities, which disproportionally affects the African-American population,
CCRTD established a Community Outreach/Education Core in 2005 as part of its research efforts. Prostate
cancer has a devastating effect on the health of African-American men; consequently it is of great concerns for
CCRTD. Since the inception of the Core, CCRTD has served as a bridge to the community and as an advocate
for action that promotes prostate health improvement. CCRTD also hosts one of the largest group of basic
research scientists in the area of prostate cancer cell and molecular biology. As part of its research activities,
CCRTD organizes weekly invited speaker seminars and journal club series and host a biennial national
prostate cancer symposium on CAU campus. These venues play a significant role in exchange of scientific
information at the local and national level. We will engage our community partners in the day-to-day function of
CCRTD and will seek input from community to guide basic research at the Center. The proposed Research
Centers in Minority Institutions (RCMI) program, Community Engagement and Dissemination (CED) core will
combine both strengths of CCRTD and create an infrastructure for development of constant interactions
between various communities with the focus on the development of the best practices for the elimination of
prostate cancer health disparities.
The Core proposes to build upon already established relationships in the community to provide researchers
and community members with the recognized need of community engagement in academia, where the value of
research evidence and community wisdom will provide effective strategies to address health disparities. This
multi-faceted approach will ensure the Center’s meaningful community participation in research, training, and
dissemination activities. Recognizing that effective community partnerships are constructed over time through
trust, respect, and commitment, the strategies and tasks of the Core will be to foster and support the
emergence of community engaged or participatory research relationships.
The CCRTD is committed to reducing disparities in cancer burdens among minority population groups and to
achieving health equality through its programmatic education and dissemination strategies. The Core plans to
expand these community education activities to increase prostate cancer awareness among African-American
men. In addition, the Core will combine its communications, information dissemination, community education,
and public health promotion strategies to guide priorities for local communication campaigns that effectively
distribute prostate cancer information to African-American communities in order to enhance informed decision-
making strategies. These health education activities will help the CED to use optimal, culturally sensitive
approaches, as well as gain insights to adapt strategies to enhance inclusion of underrepresented populations.
The goal of the CED program is to increase more effective strategies to improve prostate cancer outcomes by
using the community-academic partnership approach and will focus on two aims. In aim 1, CED will create
mechanisms to communicate prostate cancer research findings to the lay and scientific community. We will
expand upon CCRTD’s current community-based organizations, i.e., schools, churches, ministerial alliances,
advocacy groups, etc. to create an environment where the lay and scientific community come together to have
mutual dialogue and interaction about cancer research being conducted in laboratories of CCRTD
investigators. We will employ mechanisms such as the CCRTD Patient Registry, National Symposium on
Prostate Cancer, Weekly Seminar Series and Tailored Community Engagement Focus Groups to
communicate cancer research being done in the laboratories to the lay community. In aim 2, we will create an
environment where the lay community influences all phases of the research. This aim will utilize the
Community Engagement Health Inequity Seminar Series, pilot projects and several media outlets within the
Atlanta metropolitan area to have the lay community contribute to basic research being conducted in CCRTD
laboratories. We will solicit recommendations and directives from the lay community regarding their concerns
related to cancer research to assist investigators in establishing research avenues in their laboratories.

Public health relevance
Narrative The incidence of prostate cancer is 1.6 and the mortality rate is ~ 2.5 times higher in African-American men when compared to Caucasian men. The reasons for this increased risk for African-American men could be due to inherent biological differences and/or socio-economic reasons. Combined strategies based on basic biological research and community outreach programs are required to combat this disease in the African- American community. The proposed Research Centers in Minority Institutions (RCMI) program, Community Engagement and Dissemination (CED) core will combine both strengths of CCRTD and create an infrastructure for development of constant interactions between various communities with the focus on the development of the best practices for the elimination of prostate cancer health disparities. We will expand upon CCRTD’s current community-based organizations, i.e., schools, churches, ministerial alliances, advocacy groups, etc. to create an environment where the lay and scientific community come together to have mutual dialogue and interaction about cancer research being conducted in laboratories of CCRTD investigators. We will create an environment where the lay community influences all phases of the research. This aim will utilize the Community Engagement Health Inequity Seminar Series, pilot projects and several media outlets within the Atlanta metropolitan area to have the lay community contribute to basic research being conducted in CCRTD laboratories.